Huntsman Cancer Institute (HCI) Cancer Genetics, Epigenetics, Models, and Signaling (Cancer GEMS) Training Program

PROJECT SUMMARY
We propose the Huntsman Cancer Institute (HCI) Cancer Genetics, Epigenetics, Models, and Signaling
(Cancer GEMS) Training Program. HCI is a National Cancer Institute-designated Comprehensive Cancer
Center and the official Cancer Center of the State of Utah. Contributing to HCI’s mission of reducing morbidity
and mortality from cancer, GEMS provides a robust two-year predoctoral training program that leverages HCI
research strengths in cancer genetics and epigenetics, cancer modeling, and cancer cell signaling, plus
integrates trainee interactions with cancer patients, cancer clinicians, and our Disease Centers, to provide
broad multidisciplinary training in cancer biology. The program goal is to prepare young scientists who are
broadly trained in cancer biology and well-versed in multidisciplinary research approaches for impactful and
rewarding opportunities in cancer-focused post-doctoral fellowships or other cancer-related research-intensive
career paths. We have carefully selected 28 experienced HCI members to serve as training faculty, with an
additional 12 promising junior faculty as associate mentors. The GEMS program will support six predoctoral
candidates per year. Trainees will be recruited into mentor’s laboratories after entering the University of Utah
(U of U) via graduate programs in Molecular Biology, Biological Chemistry, Public Health, and Population
Health Science. The program will also recruit students from our MD-PhD program. These graduate programs
recruit an average of 69 students annually, ensuring a deep pool of potential GEMS participants. GEMS
trainees will be selected based on their academic performance, promise as cancer researchers, and
commitment to transdisciplinary cancer training. Training in the GEMS program includes courses in basic and
clinical cancer biology and cancer-focused electives. To complement these didactic courses, our trainees will
have multiple opportunities to understand cancer from a clinical and patient-centric perspective. These
opportunities include broad exposure to cancer as a disease, including interactions with patients, exposure to
different operational units within HCI, physician shadowing, and attendance at Treatment Planning
Conferences. These activities are buttressed by Research-In-Progress presentations, a career development
series, and participation at an annual GEMS trainee retreat. The GEMS program is strengthened by optional
training activities, including a Master of Science in Clinical Investigation and a certificate in Genome Sciences.
GEMS trainees will receive experimental and career development advice, the latter guided by required
Individual Development Plans, from their mentor and their thesis committee. The GEMS leadership team will
receive guidance from an External Advisory Committee comprised of leaders of successful NCI T32 programs
and a Steering Committee comprised of U of U education leaders. We will use professional evaluation tools to
ensure the effectiveness of the GEMS program, and we will track trainees following completion of the program.

Public health relevance
PROJECT NARRATIVE The Huntsman Cancer Institute (HCI) Cancer Genetics, Epigenetics, Models, and Signaling (Cancer GEMS) Training Program will support six PhD candidates each year. Students will participate in a two-year training program consisting of a combination of mentored research, didactic courses, career development activities, seminars, and conferences, all aimed at preparing these young scientists for the next stage of their careers in cancer research. This program will produce a cadre of new scientists capable of working with physicians to develop improved and individualized methods of cancer prevention, early detection/interception, and treatment.